Project 1: Small Molecule Entry Inhibitors of Pandemic Viruses

Project 1 – Small Molecule Entry Inhibitors of Pandemic Viruses
ABSTRACT
Coronaviruses (CoVs), arenaviruses (Arv), flaviviruses (FLAVs) and filoviruses (FiVs) are enveloped
viruses. During virus entry, receptor binding and refolding of the fusion protein, followed by lipid mixing, are three
essential steps to release the viral genome. Inhibitors of any one of the three steps may be developed as effective
antiviral drugs. Aim 1. Screen. (A) DEC-Tec screen using the purified ectodomain of the SARS2 S protein,
glycoprotein of Machupo virus (MACV) and envelope (E) protein of Zika virus (ZIKV). (B) HTS will be carried out
using fluorescence assays by targeting the six-helix bundle (6HB) of SARS2 and by competition with compound
ALD-1.2 that binds ZIKV E protein. (C) Virtual screens by AutoDock or other computation methods will also be
conducted since 3D structures of all target proteins are available. Aim 2. Optimization. Mechanism of action by
hit compounds. (SARS2) Hit compounds from aim 1A will be validated by time of addition inhibition assays based
on cell culture infection of SARS2 pseudotype. Validated entry inhibitors will be screened for inhibition of receptor
binding by the S protein, and formation of 6HB. The receptor binding assay is by ELISA using an ACE2-Fc
protein. The 6HB assay is set up by binding a fluorescently labeled HR2 peptide to 5HB. Entry inhibitors of other
viruses will follow the same study approach. Inhibitors of lipid mixing. In preliminary efforts, we have identified
three inhibitors that have EC50 values as low as 190 nM for SARS2 infection of cell culture. Mechanistic studies
confirm that these inhibitors interact with the transmembrane domain of the fusion protein and block membrane
fusion during virus entry. The experimental design for optimization is presented. Ebola virus entry inhibitors.
These inhibitors are at an advanced stage and serve as a proof-of-concept example for our strategy. Med Chem
Optimization. Structure and QSAR-based optimization of the inhibitor compounds will be carried out in
collaboration with Cores C and D. Candidates that meet the criteria for further evaluation will be advanced to
DMPK/toxicity studies (Core C). Escape mutants. The state-of-the-art approach is developed to evaluate
mutants that escape the antiviral activities of the inhibitors, to aid inhibitor optimization. Aim 3. In vivo efficacy.
For SARS2, lead candidates, especially prodrugs, will be evaluated for broad antiviral activities against multiple
SARS2 and SARS isolates. Potent candidates will be evaluated in hamster and mouse models. For Arv, Stat1-/-
and Ifnar1/Ifnar2 double knockout mice will be used as infection models. For Ebola virus, we have identified a
series of small molecule inhibitors targeting the Ebola GP with a novel mechanism. We will evaluate and adapt
these for the broad-spectrum activity against other significant filoviruses and evaluate their in vivo efficacy in the
animal model operating at ABSL4. Top ZIKV inhibitors will be tested in animal models against multiple ZIKV
infections. All technical work is carried out in Core E.

Public health relevance
Project 1 – Small Molecule Entry Inhibitors of Pandemic Viruses NARRATIVE Receptor binding and refolding of the fusion protein, followed by lipid mixing, are three essential entry steps to release the genome of enveloped viruses to initiate replication. Inhibitors of any one of the three steps may be developed as effective antiviral drugs. We have devised strategies to design small molecule entry inhibitors of coronaviruses (CoVs), arenaviruses (Arv), flaviviruses (FLAVs) and filoviruses (FiVs).